PsychENCODE Data Analysis and Coordination Center

PROJECT SUMMARY/ABSTRACT
We outline a comprehensive plan for the PsychENCODE Consortium’s Data Analysis and Coordination Center
(DACC), which will play a pivotal role in orchestrating and enhancing the collective efforts of the Consortium.
The DACC will be dedicated to curating, submitting, and harmonizing diverse datasets generated by the
Consortium, a crucial step in achieving the overarching goals of the Project. Guided by the expertise of Drs.
Zhiping Weng (MPI), Mark Gerstein (MPI), and Daifeng Wang (Co-I), who have been integral members since
the Consortium’s inception, the DACC's mission is to foster a collaborative environment that enables efficient
data processing, integrative analyses, and seamless communication among Consortium members. The DACC
will undertake a three-fold approach, encompassing Data Coordination, Data Analysis, and Consortium
Administration. With a focus on efficient data management, the DACC will execute data wrangling, quality
control, and curated data submission to the NIMH Data Archive. The DACC's expertise in data analysis will
shine through integrative approaches, network construction, key regulator identification, and pipeline
optimization, leading to comprehensive insights that enhance our understanding of neuropsychiatric disorders.
Moreover, the DACC is poised to leverage complementary public resources, like the BRAIN Initiative and
developmental GTEx, broadening the PsychENCODE resource's impact. Facilitating communication and
collaboration remains central, with the DACC poised to support Consortium-wide activities, ensure smooth
information flow, and host annual meetings. Through these initiatives, the DACC will foster coordination,
knowledge sharing, and scientific advancements within the Consortium. As we chart this ambitious course, we
remain dedicated to our mission of driving progress in understanding the molecular underpinnings of mental
health and illness. The project has three aims: (1) Data Coordination: efficiently process, curate, and submit
Consortium-generated data and metadata while establishing tools for data retrieval and visualization; (2) Data
Analysis: conduct integrative analyses, collaborate with Consortium members on joint data analyses, and
leverage external resources to extract comprehensive insights into neuropsychiatric disorders; and (3)
Consortium Administration: foster communication, coordinate activities, and host collaborative meetings,
enhancing coordination and knowledge sharing within the PsychENCODE Project.

Public health relevance
PROJECT NARRATIVE This proposal presents a detailed plan for the PsychENCODE Consortium’s Data Analysis and Coordination Center (DACC), which will play a crucial role in coordinating and enhancing the joint endeavors of the Consortium. The DACC will be dedicated to curating, submitting, and harmonizing diverse datasets produced by the Consortium. By emphasizing efficient data management and fostering collaboration, the DACC aims to support the Consortium's progress in accelerating our knowledge of brain function and neuropsychiatric disorders.